Optimized Circadian Rhythms for the Prevention of Alzheimer's Disease

Geroscience hypothesis posits that aging itself is the underlying major risk factor for
age-related chronic diseases, including Alzheimer's Disease (AD); therefore, delaying
aging delays disease, including AD. This proposal will examine the reciprocal relationship
between circadian rhythm disruption (CRD) and AD pathology. Circadian rhythms, which are
intimately interlinked with cellular metabolism, orchestrate the coordinated expression
and function of multiple pathways that support normal cellular function and repair in both neural
and peripheral tissues. Circadian rhythms deteriorate with aging, and Alzheimer's patients show
disrupted circadian rhythm. However, the causal role of CRD for AD is not clear. The proposal will
assess the relationship between circadian rhythm disruption and AD pathology, will test whether
improvement in circadian rhythms delay the onset and progression of AD. and will attempt to
identify underlying molecular mechanisms.
Well-characterized Drosophila melanogaster (fruit fly) models of AD with Drosophila genetic tools
will be used to test the impact of genetic or environmental CRD on the onset and severity of the
multiorgan functional decline in AD. One feature of CRD is the lack of feeding consolidation to
daylight hours in diurnal animals. To restore aspects of circadian rhythm in older flies, animals
will be subject to time-restricted feeding (TRF) in which food is provided to flies only during the
12 h day time. TRF does not reduce daily caloric intake and imparts a molecular signature that is
distinct from that under caloric restriction. Disease onset and severity will be assessed in TRF,
and ad lib fed (ALF) flies to determine if TRF is an effective behavioral intervention for AD. To
test the molecular pathways mediating the opposite effects of CRD and TRF on AD pathologies,
time-series transcriptomes from these flies will be analyzed to find candidate pathways. The
functional significance of these pathways will be tested by expressing genetic gain of function and
loss of function alleles in AD flies. Our novel in vivo genetic-transgenic Drosophila disease
model coupled with ultrastructural, functional, metabolic, and transcriptome techniques will
generate unbiased insights into the mechanistic basis of accelerated aging in production of AD.
Successful completion of this project will provide a deeper molecular understanding of the
interaction between circadian rhythm and genetic risk of AD. Additionally, this research
will assess the efficacy of a behavioral intervention that would have a high potential for
adoption in humans.

Public health relevance
Sleep and circadian rhythm deteriorate with aging and compromise the function of the brain and body. This proposal suggests a method for investigating how chronic circadian rhythm disruption, which is intimately interlinked with cellular metabolism, affects Alzheimer's disease (AD) pathology. Conversely, optimum eating time will be used a novel intervention to optimize circadian rhythm and reduce the severity of AD pathology.